Optimizing AAV delivery of bNAbs for HIV prevention

PROJECT SUMMARY
HIV-1 broadly neutralizing antibodies (bNAbs) are currently under clinical evaluation for their ability to prevent
transmission. Until a conventional vaccine is realized, repetitive dosing of a bNAb would be necessary to
maintain protective antibody concentrations. An alternative to passive infusion of bNAbs is to use adeno-
associated virus (AAV) vectors that can turn muscles into antibody production factories. This one-time
treatment would have clear cost advantages over the continuous production, purification, and administration of
recombinant monoclonal antibodies. However, host immune responses limit the efficacy of AAV vectors.
CD8+ T cell clearance of AAV transduced muscle cells limits the total number of cells producing the antibody,
and pre-existing immunity to AAV capsids limit the number of possible individuals that can receive AAV
vectors. We and others have previously shown that host immune responses are detrimental to AAV-delivered
HIV-1 antibodies resulting in low to no detectable serum concentrations. Thus, overcoming the host immune
response to the AAV vector and expressed transgene is critical for future evaluation of AAV-delivered antibody
studies in non-human primates. One area of investigation for limiting a host immune response would be to
utilize immune checkpoints that regulate immune system pathways. To this end, in a pilot study, we have
observed about a 21-fold increase in concentrations of an HIV-1 antibody in rhesus macaques when
macaques were co-inoculated with an AAV vector encoding rhesus macaque PD-L1. PD-L1 functions in
binding T cell expressed PD-1 to inhibit the cytolytic and degranulation functions. It also helps in the
development of regulatory T cells. Thus, we hypothesize that expression of PD-L1 on muscle cells transduced
by AAV vectors to express antibodies will avoid T cell clearance and maintain expression of the antibody.
Here we seek to demonstrate that co-inoculation of vectors encoding PD-L1 will result in serum concentrations
of a bNAb that will protect rhesus macaques from repetitive, low-dose SHIV challenges. Additionally, we will
develop this system by evaluating strategies to reduce the dose of AAV vector. Furthermore, we will engineer
AAV transgene cassettes and assess novel a novel AAV capsid for increasing expression from intramuscular
inoculation. Together, the results from these studies will provide a foundation for AAV gene therapy studies in
non-human primates as well as lead to the development of novel AAV vectors for expressing HIV-1 bNAbs.

Public health relevance
PROJECT NARRATIVE Adeno-associated viruses (AAV) can be used as gene therapy vectors to deliver and express broadly neutralizing antibodies (bNAbs). One current setback is the host immune response to the vector and expressed bNAb that limits the protective efficacy of the bNAb. Here we use novel strategies to limit the host immune response against AAV-expressed bNAbs, allowing us to optimize expression and evaluate bNAb protective efficacy from SHIV challenges.